Mechanisms of DFrizzled-RNP Nuclear Egress

DESCRIPTION (provided by applicant): The major goal of this project is to understand the mechanisms by which the postsynaptic apparatus is laid down and remodeled during synapse development and plasticity. In addition, a major goal is to expand my training, gain new skills, and acquire a rich foundation upon which I will build my own independent lab. A central question in neuroscience regards the mechanisms by which gene expression is regulated during synapse development and plasticity. Emerging research suggests that Wnt signaling plays fundamental roles in synapse development and function and is at the cross-road of devastating nervous system diseases. Studies in my lab have discovered a non-canonical Wnt signaling pathway, the Frizzled Nuclear Import (FNI) pathway, which is essential for the formation and modification of the postsynaptic apparatus at the developing neuromuscular junction in Drosophila. Upon signaling by the Wnt Wingless (Wg), the Wnt receptor, dFrizzled 2 (DFz2) is internalized, cleaved, and the resulting C-terminal fragment (DFz2C) translocates to the nucleus. In the nucleus, DFz2C localizes to prominent foci at the periphery of muscle nuclei, which associate with large ribonucleoprotein (RNP) granules. These RNP granules contain synapse-specific mRNA transcripts and their formation is regulated by synaptic activity. Unexpectedly, these granules exit the nucleus in a manner independent of nuclear pore complexes, by budding directly through the nuclear envelope, a process thought to be exclusive for the nuclear egress of Herpes nucleocapsids. These findings suggest a novel nuclear export mechanism challenging a major dogma in cellular biology. The goal of this project is to determine the mechanism by which these RNP granules escape the nucleus by nuclear envelope budding and to understand its impact during synapse development. The specific aims of this project are (1) To test the hypothesis that Dap160, a dynamin and atypical PKC binding protein, mediates nuclear envelope budding of DFz2C-RNPs and that its function is required for normal development and function of the NMJ. (2) To carry out a RNAi screen searching for components mediating nuclear envelope budding. These studies are expected to be highly significant in our understanding of synapse development, cellular biology, and human health. They will provide fundamental information on how Wnt signaling links synapse development to regulation of mRNAs, they will substantiate a novel mechanisms of nuclear export, and they will advance our ability to treat diseases of the nuclear envelope, such as Laminopathies, and Herpes infections such as Shingles, which remain dormant in the nervous system before becoming active.

Public health relevance
PUBLIC HEALTH RELEVANCE: Relevance The findings in this project will elucidate pathogenic mechanisms for diseases associated with the nuclear envelope, including muscular dystrophies and premature aging. Additionally, these results will further our understanding of herpes viral infections, and identify targets for novel therapeutic interventions to treat these infections. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The major goal of this project is to understand the mechanisms by which the postsynaptic apparatus is laid down and remodeled during synapse development and plasticity. In addition, a major goal is to expand my training, gain new skills, and acquire a rich foundation upon which I will build my own independent lab. Local protein synthesis has emerged as an important regulator of new synapse formation[61]. However, the specific signaling mechanisms that lead to the formation and localization of locally translated messages at synapses are still poorly understood. Studies have demonstrated that a Wnt signaling pathway, the Frizzled Nuclear Import (FNI) pathway, is essential for the formation of the postsynaptic apparatus[16, 17]. In the FNI pathway, the release of the Wnt Wingless (Wg) results in internalization of the Wg receptor DFrizzled 2 (DFz2). The C- terminal of DFz2 (DFz2C) is then cleaved, and enters the nucleus becoming localized to prominent foci in the periphery of muscle nuclei. Disruption of the FNI pathway results in loss of synapse-specific proteins necessary for proper formation of the postsynaptic apparatus at the neuromuscular junction (NMJ), such as the scaffolding PDZ protein Discs-Large (DLG), and postsynaptic glutamate receptors (GluR)[14, 15, 21]. We have demonstrated that the nuclear Frizzled receptor fragment associates with large ribonucleoprotein (RNP) particles, a process that is regulated by synaptic activity[19]. These particles contain mRNA transcripts encoding synapse specific proteins and notably, these DFz2C-RNP granules appear to exit the nucleus in a manner independent of the nuclear pore complex, budding directly through the nuclear envelope (NE). This mechanism resembles the nuclear exit of Herpes-type viruses (HSV), and was previously thought to be an export mechanism exclusive to these viruses[28]. DFz2C-RNP export requires the nuclear intermediate filament protein, Lamin C (Lam), an A-type lamin known to be linked to various types of muscular dystrophies collectively known as laminopathies[62]. Similar to nuclear HSV egress[30], the nuclear budding of DFz2C-RNP granules requires atypical Protein Kinase C (aPKC), which phosphorylates Lam, resulting in a reorganization of the nuclear lamina, facilitating nuclear export through NE budding[31]. In this project I will determine the molecular mechanisms of nuclear DFz2C-RNP granule export. These studies are expected to be highly significant in several regards. First, they will provide fundamental understanding of how Wnt signaling links synapse development to regulation of mRNAs required to build the synapse. Second, they will supply key insights in the etiology of diseases associated with the NE, such as laminopathies, by identifying targets for the development of clinical interventions to treat these disorders. Finally, they will advance our ability to cure HSV associated infections by elucidating the cellular machinery required for nuclear HSV egress. Aim1: To test the hypothesis that Dap160 mediates nuclear envelope budding. In a pilot screen designed to uncover molecular components required for RNP nuclear egress (see below), we identified an exciting likely mediator of nuclear budding, Dynamin-associated protein-160 (Dap160). Dap160 localizes to lamin foci, and downregulating Dap160 results in accumulation of DFz2C-RNP granules, and decreases in aPKC levels at lamin foci at the NE of cultured cells. Ultrastructural analysis reveals a likely nuclear export defect. Furthermore, downregulation of Dap160 in vivo, results in a phenotype similar to FNI pathway mutants. In this aim I will determine the function of Dap160 in the budding of DFz2C-RNP granules at the inner nuclear membrane (INM). Using high-resolution imaging and genetic manipulations of Dap160, I will determine how Dap160 facilitates export of large RNPs from the INM. In addition, I will examine the consequences of interfering with Dap160 in postsynaptic cells in synapse development and function, Understanding Dap160 function in FNI mediated postsynaptic development will yield mechanistic insight into this RNP export pathway and lead to the further identification of additional proteins required for this pathway. Aim 2: To test the hypothesis that protein machinery exists within cells for nuclear exit of large RNP granules through nuclear envelope budding. While it was believed that nuclear egress through NE budding was the exclusive domain of viruses, our studies support the model that this mechanism is an endogenous process for large RNP export. In this aim we will identify the cellular machinery required for this novel type of nuclear export. Towards this end, we have performed a pilot screen using cultured cells and have already identified some candidate genes involved in regulating DFz2C-RNP granule nuclear export. This screen was limited to targets that participate in vesicle trafficking. In this aim, I will expand this screen using a high throughput, whole-genome RNAi approach. This unbiased screen will allow for rapid detection of relevant proteins and provide fundamental information on the cellular machinery involved in this novel mode of nuclear export. It will also provide a wealth of targets for future in-depth analysis of how Wnt signaling regulates synapse development. While the whole genome screen is likely to provide important mediators of nuclear egress through budding, it will likely yield many more targets than can be studied during this fellowship period. I propose to validate the most interesting ones in vivo, and to choose one for in depth characterization.